Epigenetic Histone Landscape Profiles in HIV

PROJECT SUMMARY/ABSTRACT
The overarching goal of this R21 proposal is to test the hypothesis that DNA vaccines induce durable innate
memory in HIV-infected humans by characterizing the evolution of the epigenetic and transcriptional landscape
in subjects who have been immunized using a novel HIV DNA vaccine. We recently used a “systems
immunology” approach to successfully map the epigenomic and transcriptional landscape of immunity to
influenza vaccination in healthy humans. Vaccination against seasonal influenza, with or without AS03 adjuvant,
resulted in persistently reduced expression of H3K27ac in monocytes and myeloid dendritic cells (mDCs), which
was associated with impaired cytokine responses to toll like receptor (TLR) stimulation. Single cell analysis
revealed an epigenomically-distinct subcluster of myeloid cells with reduced chromatin accessibility at activator
protein-1 (AP-1) targeted loci after vaccination, persistently increased chromatin accessibility at loci targeted by
interferon (IFN) response factors (IRFs), which was associated with elevated expression of antiviral genes, type
1 IFN production, and heightened resistance to infection with the heterologous viruses Zika and dengue. In
another recent paper, we have shown that the Pfizer-BioNTech mRNA prime-boost vaccine (BNT162b2) resulted
in enhanced innate immune responses, evidenced by a greater frequency of CD14+CD16+ inflammatory
monocytes, higher plasma IFN-γ, and a transcriptional signature of innate antiviral immunity. We will replicate
this “systems immunology” framework to characterize innate memory using peripheral blood mononuclear cells
(PBMCs) from HIV+ subjects in the A5369 prime-boost DNA vaccine trial (NCT03560258). Induction and
durability of innate memory will be studied across 3 aims in this R21. Aim 1 will identify histone posttranslational
modifications (HPTMs) in PBMCs at single-cell resolution using Epigenetic Landscape Profiling using Cytometry
by Time Of Flight (EpiTOF). We will test the hypothesis that antigen-specific DNA vaccination induces innate
memory through epigenetic reprogramming, expands with each sequential prime and boost (week 0 < week 6
<< week 26), and is preserved at week 48. Aim 2 will identify gene transcript modules, and their evolution over
time, associated with innate memory. We will test the hypothesis that antigen-specific DNA vaccination induces
durable innate memory through transcriptomic changes and expands with each sequential prime and boost
(week 0 << week 26 > week 48). We will test the hypothesis that transcriptional modules that characterize innate
memory in influenza and SARS-CoV-2 vaccination are generalizable to HIV DNA vaccines. We also expect to
identify unique subsets of cells, transcripts, and pathways associated with innate memory that differ from
influenza and SARS-CoV-2. Aim 3 will perform systems immunology analysis by integrating EpiTOF and
transcriptomic data from Aims 1 &2, and comparing with similar data from influenza and SARS-CoV-2 vaccinated
subjects testing the hypothesis that there are generalizable mechanisms underlying innate memory across
vaccine platforms, and cells and pathways specific to DNA vaccines and/or HIV infection.

Public health relevance
PROJECT NARRATIVE. Almost nothing is known about innate memory in human patients living with HIV, or in HIV+ patients who are vaccinated. These studies will apply EpiTOF and CITE-seq to characterize blood cells from subjects enrolled in the ACTG A5369 DNA vaccine trial of HIV+ individuals to characterize innate immunity.